Scripps Clinical and Translational Science Hub

PROJECT SUMMARY / ABSTRACT
The Scripps Research Translational Institute (SRTI) is the foundation for the Scripps hub and is dedicated to
accelerating science that will improve human health. SRTI’s emphasis on genomics, digital medicine, and
informatics/analytics fosters a multi-dimensional understanding of individualized human health. The Scripps hub
has previously included the Scripps Research Institute (SR) and Scripps Health (SH) as principal partners,
including Rady Children’s Institute of Genomic Medicine (RCIGM) for genomic medicine initiatives and California
Institute for Medical Research (Calibr) for drug repurposing / discovery. In the new CTSA cycle, our partners
have expanded to include San Diego State University (SDSU), enabling us to combine forces in computer
science, artificial intelligence, biosensors, and diversity inclusion and equity initatives.
SRTI’s expertise in genomics was highlighted during the pandemic. We became one of the country’s most
productive sequencing centers for SARS-CoV-2 by rapidly forming the “SEARCH” alliance to process samples
with the San Diego County Department of Health, UCSD, Sharp Health, California Department of Public Health,
Helix, and our partners RCIGM and SH.
Digital medicine has been one of SRTI’s core strengths, having pioneered the first remote, site-less digital clinical
trial and now expanding this methodology to address many other medical conditions such as health during
pregnancy and sleep disorders. Our Digital Trials Center launched the Digital Engagement & Tracking for Early
Control and Treatment Scripps (DETECT) study, and in a matter of weeks our team was able to accurately
predict the likelihood of Covid with SARS-CoV-2 using passively collected resting heart rate data from wristband
sensors and later to identify a physiologic signature that correlates with Long Covid (Post-Acute Sequelae or
SARS-CoV-2 Infection).
The Scripps hub will innovate clinical and translational science to improve human health across the lifespan and
diverse racial, ethnic, geographic and socioeconomic communities. The hub will provide a nurturing environment
for education, training, and career development with a focus on individualized health domains of genomics, digital
medicine, and biomedical informatics, to empower tomorrow’s diverse workforce.

Public health relevance
PROJECT NARRATIVE The Scripps hub brings together Scripps Research and its partners Scripps Health, Rady Children’s Genomic Medicine Institute, and newly added San Diego State University, along with many collaborating entities, to innovate and transform translational and clinical science. The three principal focus areas of SRTI—genomics, digital medicine, and informatics/analytics—are interdependent, and foster a multi-dimensional understanding of human beings, which is the true foundation of individualized medicine. The Scripps hub will relentlessly pursue innovations in translational and clinical science to promote accuracy, individualism, and democratization, with deep academic and industry collaborations, fully integrating the voice of the community and patients, with a paramount goal of reducing health inequities.